DIGITAL HEALTH SOLUTIONS FOR COVID-19: CLEAR2GO

The goal of this project is to develop a smartphone-based platform to provide irrefutable proof of testing, serologic, and vaccination status for individuals. The customized solution, called Clear2Go (C2G), maps a person’s vetted identity and biometrics to their phone and then cryptographically binds it with their COVID-19 test results or other personal health information. C2G is intended to provide individuals, employers, government agencies, and other organizations with a convenient solution to evaluate the risks associated with an individual’s return to normal work, travel, and public life activities. The aims of this project include creating the C2G solution, demonstrating that C2G can be integrated with the publicly available interface of a test laboratory portal, and conveying simulated COVID-19 test results into the C2G application. Data collected under this project will be deidentified and securely transmitted to an NIH data hub.